Thromboinflammatory pathways triggered by gut dysbiosis in patients with Lupus

Imbalances in the gut microbiome have been documented in patients with Systemic Lupus erythematosus
(SLE), an archetypic systemic autoimmune disease that is associated with great morbidity and premature
death, especially in the ~40% with Lupus Nephritis (LN). While studies of lupus-prone mice have suggested
potential microbiome-related pathogenic pathways, little is known about the mechanisms by which gut
community alterations affect lupus pathogenesis. Our recent longitudinal studies identified patients with flares
of LN, concurrent with great intestinal expansions (or blooms) of a candidate gut pathobiont species. In murine
systems, pathobiont blooms induced high-level gut permeability, microbial translocation and inflammatory
responses. To perform unbiased surveys of possible effects on immune activation, we generated blood bulk
RNA-seq libraries from groups of patients at time of high disease activity, and compared to matched controls.
We have assembled a multi-disciplinary team to now test a novel data-driven mechanistic hypothesis: that
intestinal blooms of this pathobiont contribute to lupus flares through systemic release of microbial factors
causing platelet activation and thromboinflammation, pathways first documented in patients with sepsis.
In Aim 1, we will focus on human systems, and in feasibility studies we will analyze RNA-seq libraries from
individual patients over time, to determine whether this platelet activation profile fluctuates with disease activity,
or if it represents a persistent state. We will also interrogate public data sets to investigate whether these
pathways are common in other SLE cohorts. Established in vitro assay systems will characterize phenotypic
and functional changes in platelets isolated from patients representative of bloom and non bloom active LN
groups, non-renal SLE patients and healthy controls. Using naïve human cells, and stimulation with killed
candidate pathobiont, co-cultured with strains isolated from SLE patients or healthy individuals, or pathobiont-
derived immune active components, we will directly test for in vitro capacity to directly activate human
platelets, implicated in the pathogenesis of LN.
In Aim 2, we will assess the feasibility of using murine models, by in vitro and in vivo testing, to assess
whether components of the gut microbiome trigger these postulated immune pathways implicated in Lupus
pathogenesis. Our mechanistic studies will utilize the same set of stimulants and microbiome factors used in
Aim 1 in established murine models emulating the human system.

Public health relevance
Project Narrative Our understanding is limited regarding what triggers serious disease flares in patients with Systemic Lupus Erythematosus (SLE), a condition responsible for major disability and premature death, which disproportionately affects women, under-represented minorities and the economically disadvantaged. From studies of the microbial communities that reside in the gut of SLE patients, paired with blood RNA-seq libraries in these patients, we identified patients with Lupus Nephritis (LN), often the most severe and unpredictable form of disease, who have intestinal expansions of a specific pathobiont, that correlated with activation of platelets, the sentinels of the immune system. These exploratory R21 studies will break new ground and contribute fundamental knowledge on the mechanistic interconnections between the microbiome and autoimmune pathogenesis, as we test hypotheses that gut dysbiosis leads to platelet-mediated thromboinflammatory pathways, which then contribute to the pathogenesis of SLE, especially in LN.